Mechanism of action of Dapsone in Mycobacterium leprae

Project Summary
Current drug resistance surveillance for leprosy is solely based on the monitoring of clinical symptoms and
the molecular identification of specific mutations in known drug resistance genes, which are few and fail to
encompass the range of molecular mechanisms responsible for treatment failure. We used comparative
genomics of drug-susceptible and drug-resistant Mycobacterium leprae strains to identify novel molecular
markers of antibiotic resistance in leprosy. Top candidate genes whose polymorphism potentially associated
with drug resistance were characterized using a surrogate Mycobacterium (Mycobacterium tuberculosis)
since M. leprae cannot be cultured in vitro. Our preliminary results show that the deletion of one candidate
gene in particular, fadD9, in M. tuberculosis significantly enhances dapsone resistance. Analysis of the
potential function of this gene combined with the results of an earlier metabolomics study on the effects of
antifolates on M. tuberculosis metabolism point to the existence of a previously unknown target of dapsone,
independent of the FolP1 enzyme from the folate pathway, the deleterious pharmacological inhibition of which
is mitigated by mutations reducing or inhibiting the activity of FadD9. This exploratory project aims to
characterize these new mechanisms of susceptibility and resistance to dapsone in mycobacteria.
Specifically, we hypothesize that dapsone inhibits the g-aminobutyrate (GABA) aminotransferase, GabT,
responsible for the production of succinate semialdehyde (SSA) from GABA, thereby limiting the amount of
succinate entering the TCA cycle through the GABA shunt. We further hypothesize that FadD9 converts the
product of GabT, SSA, to succinaldehyde and that loss of/reduced function mutations in FadD9 thus prevent
the limited amounts of SSA produced by the dapsone-inhibited GabT from being diverted away from the TCA
cycle.
Aim 1 will use genetic and enzymatic approaches to test the hypothesis that dapsone inhibits GabT. Aim 2
will similarly use a combination of cell-free and whole cell-based approaches to test the hypotheses that (i)
FadD9 converts SSA to succinaldehyde and that (ii) clinically-relevant mutations lead to reduced or loss of
FadD9 activity. Aim 3 will finally attempt to correlate different levels of dapsone resistance in a collection of
well-defined M. leprae isolates to the presence of mutations in folP1, fadD9, and/or potentially gabT, in the
same isolates.

Public health relevance
Project Narrative This project will investigate a previously unknown mechanism of action of Dapsone in Mycobacterium leprae and decipher the strategies evolve by this bacterium to develop resistance. Success in the stated aims of this project will lead to the identification of novel molecular markers of antibiotic resistance in leprosy.